Can suicide theory-guided natural language processing of clinical progress notes improve existing prediction models of Veteran suicide mortality?

Background: Reducing suicide and suicide attempts among U.S. Veterans is a major national priority, as
more than 6,000 Veterans die by suicide every year and many more attempt suicide. In 2017, the most recent
year for which data are available, the suicide rate among Veterans was 1.5 times the rate of non-Veterans, and
the suicide rate among female Veterans was 2.2 times the rate of non-Veteran females. Current VHA suicide
risk prediction models suffer from high numbers of false negatives - Veterans not deemed at high risk of
suicide who do attempt or die by suicide. These suicide prediction models have not incorporated the rich
information from clinical progress notes that may improve our ability to predict suicidal behavior. Much of this
information in clinical progress notes is unstructured free text. A suicide-specific ontology and information
extraction system that can extract suicide-related information from unstructured clinical progress notes is not
available.
Significance/Impact: Enhancing VHA's ability to identify Veterans who are most likely to attempt suicide
ensures that limited intervention resources can be focused on Veterans with the highest risk, before they
attempt suicide or die by suicide. The proposed study is well-aligned with priorities for HSR&D research and
with VA strategic goals for 2018 – 2024 set out by VA leadership, who listed suicide prevention as “VA's
highest clinical priority.”
Innovation: Our key methodological innovation is to pair a state-of-the-art theoretical framework (3-step
Theory of Suicide) to predict who is most likely to act on their suicidal thoughts with state-of-the-art data
science methods (NLP, machine learning). Since our suicide-theory concepts, that is hopelessness,
connectedness, psychological pain, and capacity for suicide, are not represented in structured patient data, we
will develop novel NLP and information extraction tools and apply them to clinical progress notes, the potential
of which has not been fully levied to improve suicide prediction models.
Specific Aims: We have three specific aims:
1. Develop a suicide-specific ontology for machine recognition of hopelessness, connectedness,
psychological pain, and capacity for suicide in progress notes of clinical encounters with Veterans who
attempted or died by suicide.
2. Extract information on the presence and intensity of hopelessness, connectedness, psychological pain,
and capacity for suicide in clinical progress notes and describe change in these concepts in proximity of
a suicide or suicide attempt.
3. Determine the predictive validity of hopelessness, connectedness, psychological pain, and capacity for
suicide regarding Veteran suicide attempts and mortality in two prediction models that VA currently
uses in clinical practice: STORM and REACHVET.
Methodology: The proposed mixed-methods study has an exploratory sequential design where a qualitative
component (Aim 1) informs quantitative analyses (Aims 2 and 3). Data collection will be from existing clinical
progress notes in VHA's Corporate Data Warehouse, VA's Suicide Prevention Applications Network and from
the VA/DoD Suicide Data Repository. We will use linguistic annotation and thematic analysis for Aim 1 and
natural language processing and machine learning models for Aims 2 and 3. The target population is Veterans
who receive care through VHA.
Next Steps/Implementation: Our most important next step is to be in regular contact with local and national
colleagues at the VA Office of Mental Health and Suicide Prevention (OMHSP) to facilitate implementation of
our results in the operational versions of STORM and REACHVET.

Public health relevance
Suicide and suicide attempts among U.S. Veterans remain a serious concern, as more than 6,000 Veterans die by suicide every year and many more attempt suicide. Current VHA suicide prediction models do not incorporate the rich information relevant to suicide from clinical progress notes. The proposed study will use natural language processing to make this information available for suicide prediction models. The study sets itself apart from other studies in this area by employing the state-of-the-art 3-step Theory of Suicide, which aims to distinguish high-risk Veterans who will attempt suicide from high-risk Veterans who will not attempt suicide. Enhancing VHA's ability to identify Veterans who are most likely to attempt suicide ensures that limited intervention resources can focus on Veterans with the highest needs, before they attempt suicide or die by suicide. The proposed study is well-aligned with priorities for HSR&D research and with VA strategic goals for 2018 – 2024 set out by VA leadership, who listed suicide prevention as “VA's highest clinical priority.”